A Multidisciplinary Center for Developing Human and Non-human Primate Brain Cell Atlases

Project Summary
The ultimate product of our Center will be a series of comprehensive developing human and non-human primate
(NHP) brain atlases of unprecedented cellular, spatial, and anatomical resolution. In Aim 1, we will characterize
transient cell populations, establish the diversity of cell types present in specific brain regions, unravel complex
developmental trajectories, and reveal conserved and divergent cell-type specific features. We will jointly profile
of single nucleus RNA (snRNA-seq) and accessible chromatin (snATAC-seq) using the 10X Genomics
snMultiome platform. All aims will include 30 anatomically distinct regions of fresh frozen developing human,
rhesus macaque, and marmoset brains at four developmental epochs: mid-gestation, neonatal, childhood, and
adolescence and perform probe-based validation.
In Aim 2, we will conduct spatial transcriptomic and epigenomic mapping of cell types in fresh-frozen
developing human and NHP brains using DBiT spatial-RNA-seq and spatial-ATAC-seq platforms. This approach
will allow us to discover spatial and temporal features, including the developmental niche, proximity of cell types
to each other, and regional abundance. In Aim 3 we will create Common Coordinate Frameworks for the
developing human and NHP brain using high resolution (9.4T and 7T) MRI-based developmental structural
atlases and leveraging existing developing human MRI data. Our final aim will create a cross species molecular
and spatial atlas of brain development in human and NHP. This integration will enable us to identify conserved
and diveregent aspects of the human brain and identify the developmental stages, spatial distribution, gene
regulatory elements and cell types vulnerable to neurodevelopmental and neuropsychiatric disorders. We will
coordinate to ensure that our developmental atlases merge with adult human, macaque and marmoset atlases
that other BICAN centers create.
The data collected by our Center will be perfectly aligned with the overarching goal of the BICCN in
generating a comprehensive census of brain cell types across the lifespan that integrates molecular, anatomical,
functional, and cell lineage data for describing cell types in human and NHP brains. By leveraging innovations
in cell capture and spatial mapping technologies, the current proposal will have broad implications for
understanding the cellular origins of diseases and for highlighting patterns of selective cell type vulnerability in
neurodevelopmental disorders such as autism and schizophrenia. Additionally, our plans to create
developmental cellular and molecular resolution maps of marmoset and macaque will provide foundational data
for establishing primate models of human disease. Finally, our atlas of conserved molecular, epigenetic, and
spatial properties will support the precise monitoring, targeting, and replacement of specific cell types and the
improvement of in vitro models.

Public health relevance
Project Narrative We have assembled a multi-institutional collaborative center with the aim of creating a cellular taxonomy of molecularly defined cell types in the developing human, Rhesus macaque, and marmoset brain. Our project employs technologies for automated single nucleus and spatially-resolved RNA-sequencing and single cell transposase accessible chromatin sequencing to create spatial gene expression and epigenomic developmental expression maps for human and NHP brain. We will sample 30 brain regions at four key epochs of development and register our cellular data onto MRI-based Common Coordinate Frameworks to create a unique resource that will serve as a blueprint for studies of human brain function and selective vulnerability of cell types to disease and will provide foundational data for the development of primate and in vitro models.